Gout and Cardiovascular Comorbidities: Disentangling the Interplay with Advanced Methods to Address Measurement Issues

Yoshida, K. - Gout and Cardiovascular Comorbidities: Disentangling the Interplay with Advanced Methods to Address Measurement Issues. -- 2019-11-01
PROJECT SUMMARY
Candidate: I am an Associate Epidemiologist and Instructor in Medicine in the Section of Clinical Sciences, Division
of Rheumatology, Inflammation, and Immunity at Brigham and Women’s Hospital (BWH) and Harvard Medical
School (HMS). My long-term goal is to develop an independent research career as a patient-oriented researcher
contributing to the methodological advancement of clinical research in rheumatic diseases. I have a track record in
the application, development, and dissemination of rigorous quantitative methodologies. My background includes
clinical rheumatology, pharmacoepidemiology, and biostatistics. This mentored research experience will integrate
my methodological research skills into clinical research focusing on gout and cardiovascular (CV) comorbidities. I
will receive mentorship from Dr. Daniel H. Solomon, an established patient outcomes researcher with expertise in
rheumatic diseases, including gout, as well as a team of expert co-mentors consisting of Drs. Robert J. Glynn
(methodology), Brendan M. Everett (CV epidemiology), and Hyon K. Choi (gout epidemiology).
Environment: I have strong support from my Department and Division at BWH, which ensures 85% protected time
for the stated project for research and career development activities related to the proposed project during the 5-
year award period. I have financial support to supplement my salary and research-related expenses from the Divi-
sion, the Section, and my primary mentor’s funding. I have access to high-performance computing resources
through BWH and HMS, as well as access to the Canakinumab Anti-inflammatory Thrombosis Outcome Study
(CANTOS) data through Dr. Glynn’s support. The Partners Research Patient Data Registry enables Medicare
claims linkage and targeted enrollment of gout patients for patient surveys.
Research: The overarching goal of the project is to apply, develop, and disseminate state-of-the-art quantitative
methods to address measurement issues frequently encountered in rheumatology, and more specifically in gout.
Three related clinically important questions are drawn from the interplay of gout and comorbidities; all three aims
assess the impact of measurement issues. Aim 1 on “the cross-sectional association of gout and CV comorbidities”
critically assesses the impact of misclassification in understanding the population burden of gout and CV comor-
bidities. Aim 2 on “causal investigation of gout and CV events” rigorously quantifies the influence of mismeasure-
ment of gout flares and inflammatory biomarkers in mediation analysis of the potential causal link between serum
uric acid and subsequent CV events. Aim 3 on “patient-centered consideration of gout and CV disease burden”
formally evaluates the validity of existing multimorbidity indices in measuring the lived experience of patients with
gout, represented through patient-reported outcomes. For my first R01, I plan to develop and validate an automated
multimorbidity index estimator for routine care data in the electronic health record, utilizing the knowledge and skills
in mismeasurement correction obtained in Aims 1 and 2 as well as preliminary data from linked datasets (routine
data and patient survey) built in Aim 3.
1

Public health relevance
Yoshida, K. - Gout and Cardiovascular Comorbidities: Disentangling the Interplay with Advanced Methods to Address Measurement Issues. -- 2019-11-01 PROJECT NARRATIVE: Gout is a systemic metabolic disease characterized by inflammatory arthritis and high comorbidity burden in women and men. Uncertainties exist in the accurate measurement of comorbidity burden of gout and its sex differences, estimation of the biological link between gout and cardiovascular diseases, and quantification of multimorbidity that burdens patients. The project will approach these clinical problems while applying, developing, and disseminating state-of-the-art quantitative approaches underutilized in rheumatology clinical research. 2